Discovery of Stimulus-Responsive Microproteins in Human Microglia

PROJECT SUMMARY
This R21 proposal outlines a collaborative research initiative aimed at elucidating how human microglia-like
cells (iMGLs) leverage mRNA translational control mechanisms to respond to environmental cues. Human
microglia must leverage significant protein diversity to mount immune responses and shape behavior in
response to external stimuli, but the role of mRNA translation in microglial function is poorly understood.
Further, mRNA translation is far more complex than previously appreciated, as translation occurs within
regions of the genome annotated as non-coding – so-called non-canonical open reading frames (ncORFs).
ncORFs include small open reading frames (sORFs) less than 300 nucleotides that encode microproteins less
than 100 amino acids. Microproteins have been implicated as critical biological effectors of the immune
response, but the role of such microproteins in human microglia is unknown. We hypothesize that
microproteins may be an important and indispensable component of human microglia function and the
response to environmental stimuli. As such, we will define the translational landscape – the “translatome” – of
iMGLs using ribosome profiling, which allows us to map translation at single nucleotide resolution. We will
define open reading frames in iMGLs, and identify both novel sORFs and putative microproteins. We will
similarly use ribosome profiling to identify translational responses to external stimuli, such as myelin debris and
amyloid. We will confirm our findings using size-selected proteomics to validate stimuli-dependent human
microglial microproteins. The knowledge derived from this research plan will not only enhance our
understanding of the mechanisms through which human microglia respond to the local microenvironment, but
will also identify candidate microproteins that can be functionally interrogated as critical effectors of human
microglia function.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it defines novel mechanisms for human microglia to respond to disease-relevant stimuli. We will discover how human microglia leverage RNA translation to adapt to environmental conditions. The proposal is relevant to the NIH’s mission that pertains to the discovery and application of knowledge to reduce illness and disability.